Addressing Cervical Cancer Disparities Among People Experiencing Homelessness

PROJECT SUMMARY
People experiencing homelessness are at increased risk of cervical cancer incidence and
mortality and have disproportionately low screening rates compared to the general population.
Innumerable social and structural barriers keep this underserved population from accessing
preventive healthcare, including mental health and substance use disorders, low health literacy
levels, mistrust in medical providers due to stigma and discrimination, and living conditions that
disenfranchise them from health and social services. Homeless women also experience high
rates of sexual violence and trauma, often leading to discomfort with cervical cancer screening
and delays or refusals of Pap tests. Despite these issues, a common inability to engage these
“hard-to-reach” communities has largely excluded people experiencing homelessness from
cancer research or public health programs, resulting in a major paucity of data on this uniquely
vulnerable population with excess cancer burden. The proposed community-based participatory
research will meaningfully engage people experiencing homelessness and local health and
social service organizations to: 1) estimate cervical cancer screening coverage and factors
associated with unscreened or underscreened individuals in two major homeless communities
in Indiana; 2) identify key barriers and facilitators to cervical cancer screening, follow-up, and
linkage to care; 3) determine the acceptability of HPV self-sampling delivered by community
health workers, as an alternative to traditional cervical cancer screening methods; 4) elucidate
the feasibility of HPV self-sampling in terms of the ability of people experiencing homelessness
to acquire an adequate cervical sample; and 5) provide an estimate of HPV point prevalence
and distribution of infections by genotype, age, gender identity, and race/ethnicity, which is
critical to informing primary and secondary prevention strategies for this highly mobile and
undervaccinated population. By triangulating the perspectives of people experiencing
homelessness and the medical and homelessness social service providers who serve them, this
study will lead to a holistic understanding of multilevel influences on preventive health behaviors
and the potential role of alternative cervical cancer screening modalities. Leveraging an
established multisectoral campus-community partnership examining and addressing health
disparities among homeless communities in Indiana, this project will integrate behavioral and
biomedical research to identify optimal strategies that facilitate routine screening and preventive
healthcare delivery for people experiencing homelessness.

Public health relevance
PROJECT NARRATIVE People experiencing homelessness are at increased risk of cervical cancer incidence and mortality and have disproportionately low screening rates compared to the general population. Even beyond the innumerable social and structural barriers to healthcare faced by homeless populations, homeless women in particular experience high rates of sexual violence and trauma, often leading to discomfort with cervical cancer screening and delays or refusals of Pap tests. Leveraging an established multisectoral campus-community partnership examining and addressing health disparities homeless communities in Indiana, this study will examine cervical cancer screening practices and barriers among people experiencing homelessness and determine the acceptability and feasibility of HPV self-sampling delivered by community health workers.